Principles of STI/HIV Research and Public Health Practice Course

The annual “Principles of STI and HIV Research and Public Health Practice” course was launched by the University of Washington in 1993 to provide an intensive overview of skills and foundational knowledge required for research careers in the field of STI/HIV. Since then, it has evolved into a globally-recognized cornerstone of STI/HIV research training with over 3,500 participants trained to date from over 25 countries and 6 continents. The proposed R13 is for partial support of the course / training conference for the next five years. The course objectives are to train early-stage STI/HIV investigators from interdisciplinary backgrounds to: (1) Describe the biologic, clinical, epidemiological and social/behavioral aspects of STI of contemporary public health importance; (2) Identify outstanding scientific questions and develop a research design or program evaluation to answer these scientific questions; (3) Gain experience applying different strategies from research and/or public health program evaluation to answer emerging questions in the field of HIV/STI; (4) Gain experience working on a multidisciplinary team of STI/HIV researchers and practitioners and provide opportunities for social interaction and networking; (5) Discuss the different opportunities and career paths available in STI/HIV research and practice fields for US domestic and international public health; and (6) Provide opportunities for professional networking with peers and course faculty To meet these objectives, the course takes an interdisciplinary approach and provides early-stage investigators with tools for continued learning, collaboration in multidisciplinary teams, and maintaining a broad scope of investigative possibilities. This course offers a unique opportunity for state-of-the-art introductory training in behavioral, clinical, epidemiologic, statistical, implementation, and basic science research on STI/HIV through a practically-oriented overview of concepts and skills common to these broad disciplines. Course proceedings are disseminated on a UW website, which contains speakers' slides, lecture recordings, and discussion boards. The course is evaluated each year, and updates to subsequent course agendas are informed by participant feedback and Curriculum Committee recommendations to ensure the course is up-to-date, relevant, and employs active learning techniques. Participant feedback is extremely positive, demonstrating that the “Principles Course” remains a critical resource for training the next generation of HIV/STI researchers and public health practitioners.

Public health relevance
—Since 1993, the University of Washington’s annual Principles of STI/HIV Research and Public Health Practice Course has provided participants with a state-of-the-art intensive, interdisciplinary, two-week introduction to the fundamentals of behavioral, clinical, epidemiologic, statistical, implementation, and basic science research and practice in HIV and sexually transmitted infections (STI). The course is designed to increase success in identifying important knowledge gaps, asking impactful research questions, procuring research funding, and establishing cross-disciplinary research collaborations in the field of STI and HIV/AIDS.